Tools and Methods for Producing High Quality Functional Protein Microarrays for Biomarker Discovery

High-density protein arrays are critical to identifying biomarkers for the early detection of disease, confirming
specificity of commercial antibodies, identifying new protein-protein interactions, and more. Yet, access to these
arrays is still hindered by high cost, largely as a result of the high cost of individual proteins that need to be pre-
purified for printing. To facilitate access of protein arrays to the research community, INanoBio developed a
functioning semi-automated protein array production instrument that utilizes lower cost DNA arrays to express
proteins in situ, which are immediately covalently captured on a corresponding slide. The end product is a protein
array without DNA or expression reagents that is immediately ready for assay. In Phase I, we met all milestones
aimed at demonstrating system functionality, discrete protein capture, and functionality of captured proteins; we
also identified sources of variation that will be addressed in this proposal. The ProCap system was proven to
produce its capacity of four protein arrays simultaneously with over 10,000 discrete proteins per array. The
proteins captured on the array were shown to maintain known protein-protein interactions, enzymatic activity,
and substrate activity. In this proposal, we aim to develop a market-ready, user-friendly benchtop version of
ProCap called Genetein (genes to proteins). This instrument will be more compact, operate by intuitive
software, and most importantly will come pre-loaded with automation protocols for processing arrays on-
instrument to add post-translational modifications and/or probe with samples for biomarker discovery and other
assays. A key feature added to ProCap outside of the Phase I proposal was the ability to use different capture
slide substrates, adding gold biosensor slides as an option for capture and ultimately enabling the user to
investigate proteins in high throughput via surface plasmon resonance imaging. This feature will be included as
part of Genetein . Ultimately, INanoBio and external partners will build, test, field-test,
improve, and validate Genetein to ensure functionality, usability, and reproducibility. The outcome of the
proposed work will be a ready-to-manufacture Genetein instrument for sale to customers, customized and off-
the-shelf protein arrays produced on Genetein by INanoBio for shipping to customers, and a full-service option
to allow customers to ship their samples to INanoBio for processing on Genetein arrays.

Public health relevance
Proteins are the molecular machines that do much of the enzymatic and mechanical work in our cells, much of which is fundamentally governed by the unique binding strengths and affinities that particular proteins have for the other biomolecules they encounter in the crowded matrix of the cell. While many techniques exist today to study the nature of these interactions, few are able to facilitate the analysis desired at the scale required as there are hundreds of thousands of different proteins and unique variants that maintain function in healthy states, or which acquire mutations and cause disease. In this Phase II proposal, we aim to advance our initial prototype instrument, capable of synthesizing thousands of full-length and functional proteins in array format facilitating at- scale biomolecular interaction analysis, into a commercial-ready benchtop instrument with enhanced sample processing automation, fluidics control, and a user-friendly graphic interface that we hope will advance proteomics research and discoveries.